Transcriptional Regulation of Innate T cell fate

Project Summary
InnateT cells are a collection of T cells withimportant regulatory functions that have a crucial role in immunity
towards tumors, bacteria, viruses, and in cell-mediated autoimmunity. Due
large quantities of cytokines upon activation,
immune
response
populations
glycolipid
cells
T
commitment
to
innate T cells act as bridges between the innate and adaptive
systems a nd ontribute greatly In mice, this swiftness of
reflects their acquisition f functionality during their development in the thymus. Three major
within the innate T cell group are recognized namely, the invariant NKT cells that recognize
antigens presented by non-polymorphic CD1d molecules, the mucosal associated invariant T (MAIT)
that recognize vitamin metabolites presented by the non-polymorphic MR1 molecules, and the certain 
cells which antigen specificities remain uncertain. We have established an in vitro system t hat mimics the
of double positive precursor cells to the innate T cell lineage and we propose to
their ability to promptly secrete
c to immune regulation and host protection.
o
,
deconstruct the
early transcriptional and epigenetic events that accompany this fate commitment (Aim 1). In this way, we will
identify
manipulation
early factors that influence innate T cell development, providing the possibility for selective
of innate T cell lineage specification. We will then investigatewhether human innate T cells
acquire an innate-like transcriptional program in the thymus similarly to their mouse counterparts and whether
this program is shared between the two species. To do so, we will profile the transcriptomes of iNKT and MAIT
cells purified from neonatal human thymi at the single cell level. In addition, we will extend our knowledge of
innate T cell lineage commitment by also studying CD1a-restricted T cells, which do not exist in mice (Aim 2).
Given their capacity to link key inflammatory axes of innate and adaptive immunity, a better understanding of
the molecular basis underpinning innate T cell development and plasticity, and how much this feature accounts
for their pathophysiological roles, is critical for developing novel therapeutic approaches.

Public health relevance
Project Narrative The proposed studies aim to unravel the molecular details that establish the distinct transcriptional program of innate T cells, the first line of defense against multiple infectious, tumoral, allergic and inflammatory disease, and establish whether such program is shared between mice and humans. These studies will open up substantial new possibilities for understanding innate T cells development and effector programming so that it can be exploited for therapeutic usage to improve human health.